Cancer Research Training and Education Coordination

PROJECT SUMMARY/ABSTRACT
The Cancer Research Training and Education Coordination Core (CRTEC) of Perlmutter Cancer Center
(PCC) at NYU Langone Health (NYULH) coordinates and supports educational activities aimed at training the
next generation of researchers, clinicians, and professionals across the entire spectrum of cancer biology,
prevention, and care. CRTEC is directed by Mark Philips, MD, an internationally recognized cancer cell
biologist with a distinguished career in teaching and mentoring at all levels. Philips is also the Director of the
NYU Medical Scientist Training Program, providing an important liaison for the PCC. He is assisted by a
diverse Advisory Board of stakeholders with important educational roles in multiple NYULH departments.
CRTEC interacts with multiple entities across NYULH and the greater NYU campus, including the top-ranked
NYU Grossman School of Medicine (NYUGSoM), a comprehensive biomedical sciences PhD program (Vilcek
Institute) with 11 cancer-related T32 grants, a renowned MD/PhD program, post-graduate residency and
fellowship training programs in medical, radiation, pediatric, gynecological, and surgical oncology as well as
undergraduate, graduate, and professional programs in related fields, such as bioinformatics, social work,
global health, nursing, dentistry, and engineering. The programs all place priority on ensuring a diverse and
successful student/trainee population. NYULH is a nationally recognized laboratory for educational
innovation and CRTEC is a major contributor to these efforts. For example, CRTEC oversees highly
successful outreach programs to attract high school and college students, particularly underrepresented
minorities (URMs), to cancer-related careers, and it organizes the robust repertoire of educational activities
and events intrinsic to the PCC. In the next cycle, it will extend these efforts to middle school students, engage a
new high school adjacent to our campus intended to educate health care professionals, develop a new cancer-
focused elective for senior medical students, expand programs to train clinical research nurses, develop
quantitative methods to track and monitor trainee success, and support the educational components of
SPOREs and other large grants. CRTEC has three Specific Aims: 1) Support and bring cancer-focus to the
educational enterprise at NYULH, 2) Provide support, leadership, and infrastructure for the educational
activities intrinsic to PCC, 3) Develop new initiatives in cancer education.